Understanding HIV reservoir formation by profiling transcriptomic and epigenetic changes in CD4 T cells following ART initiation

During HIV infection, a reservoir of latently infected cells forms that persists during therapy, and
this reservoir represents the major barrier to an HIV cure. We and others have shown that HIV
latency is an epigenetic phenomenon, characterized by distinct changes to chromatin structure
and histone modifications that repress HIV gene expression, that can be transmitted through cell
division. This heritable property of latency allows the latent phenotype to survive ongoing clonal
expansion of infected cells in hosts and sustain the overall reservoir. Furthermore, viral silencing
and epigenetic programming is linked to global changes that occur within CD4 T cells as they
transition from an activated to a resting state. Fully defining the process by which the reservoir is
formed and by which latency is programmed will be essential to guiding novel approaches to
prevent reservoir seeding or maintenance. To date, studying the process of reservoir formation
during clinical HIV infection has been considered difficult, if not impossible, due to prior
observations suggesting that the reservoir forms very early during acute infection. Newer
information from several groups, however, has now revealed that the majority of the reservoir is
seeded by viruses that are actively replicating at the time of ART initiation, suggesting that ART
initiation triggers seeding of the reservoir. This observation raises the exciting possibility that
we could potentially study the process of reservoir seeding by longitudinal observation of CD4 T
cells from PWH in the immediately post ART period and, by doing so, reveal potential ways to
block the reservoir from forming at the time of therapy initiation. In this proposal we aim to
comprehensively define epigenetic and chromatin-based changes that occur in CD4 T cells in the
post ART period using samples derived from the A5248 cohort. CD4 T cells from these samples
will be profiled using a series of cutting-edge assays that have been established and validated in
our laboratory. These assays include combined single-cell multi-omic (RNAseq/ATACseq)
analysis, and high-resolution genome-wide mapping of multiple key histone modifications through
Cleavage Under Targets and Release using Nuclease (CUT&RUN). From this approach we will
achieve an integrated understanding of how heritable patterns of chromatin-based changes in
CD4 T cells are triggered by ART initiation and generate novel and critical insights into the
intracellular conditions that coincide with reservoir seeding in vivo. By achieving this goal, we will
reveal mechanisms that promote reservoir seeding and suggest novel approaches to block
reservoir formation at the time of ART initiation.

Public health relevance
Understanding how the latent HIV reservoir forms is critical to developing new strategies to eliminate infected cells from people with HIV. Recent data has shown that the majority of the reservoir forms in a defined temporal window that coincides with the initiation of anti-retroviral therapy (ART). In this proposal, we aim to define transcriptional and epigenetic changes that occur in CD4 T cells during ART initiation by characterizing longitudinal samples from a clinical cohort and reveal how the intracellular state of CD4 T cells promotes viral silencing and epigenetic repression of HIV.